The Role of Androgens on Breast Cancer Susceptibility across the Lifecourse.

Project Summary/Abstract
Despite extensive research on the role of estrogens in breast cancer risk, little is known about the role of
androgens, an important precursor to estrogen, in altering breast cancer susceptibility. Further, there is a
critical need for etiologic investigation of the role of androgens in women and adolescent girls who are at
higher risk of breast cancer from their family history of breast cancer. The proposed project will address this
major gap in scientific evidence through an integrated program of training and research using longitudinal
family-based cohorts to investigate the effect of dynamic androgen patterns on breast cancer risk across the
lifecourse. Reproductive risk factors in breast cancer risk models (e.g., age at menarche, age at first birth,
parity) are proxies for estrogen exposure, but such factors incompletely capture the hormonal environment,
particularly androgen levels, which rise prior to puberty and are affected by other processes including stress.
Some improvement in risk assessment has been seen using serum concentrations of single androgenic or
estrogenic hormones. This proposal will investigate the full steroid hormone metabolome, including androgen,
estrogen, progestagen and glucocorticoid metabolites, in relation to breast cancer risk. Measurement of
androgens levels, as opposed to estrogens that vary more across the menstrual cycle, is more feasible in
adolescents and pre-menopausal women and thus likely will be more useful in clinical risk assessment.
Through use of ongoing family cohorts with existing biospecimens, we will investigate whether the magnitude
of the associations between androgens and breast cancer risk and androgens and intermediate risk factors
(puberty and menstrual cycle characteristics) differ in populations with high, intermediate and low underlying
genetic susceptibility, a critical question for accurate risk assessment. Specifically, we will analyze data from
two longitudinal studies enriched with girls and women with a family history of breast cancer, which represents
underlying genetic susceptibility to cancer. The first is a prospective nested case-control study of women
participating in the Prospective Family Study Cohort (n=75 cases, 150 controls from a cohort of 2,136
unaffected women). The second is the LEGACY Girls study, a multi-site cohort that enrolled 1040 girls ages 6-
13 years at baseline and has followed them semi-annually for the past six years. Analyses in these cohorts will
include three key periods—adulthood, adolescence and childhood—to address specific hypotheses focusing
on urinary androgen metabolites and breast cancer, puberty, body size, and early-life stress. We will use
mobile health methods to track menstrual cycles in real time to better characterize hormone patterns. The
proposed research will be complemented by experiential and didactic training in 1) family-based study design
and risk assessment, 2) mechanistic- and trajectory-based analytics, 3) dissemination and implementation
science. This research and training will launch a program of independent research on the genetic and
biocultural factors shaping girls and women's hormone trajectories and breast cancer risk.

Public health relevance
Project Narrative The incidence of invasive breast cancer in young women is increasing in the US; however, current risk assessment models and screening tools, which are designed for older women and predominantly rely on family history, are inadequate to identify young women at risk. Steroid hormones, which we hypothesize are programmed during puberty, may improve breast cancer risk assessment for individuals with and without a breast cancer family history. Identifying early-life factors, such as stress and body size, that shape adult steroid hormone production is important for informing interventions, such as mobile health screening tools, that can be implemented into health and risk assessment in young adults for breast cancer prevention.